Leadership, Planning and Evaluation

PROJECT SUMMARY – LEADERSHIP, PLANNING AND EVALUATION
Under University of Wisconsin Carbone Cancer Center (UWCCC) Director Howard Bailey, MD, a number of
critical steps were taken in the planning and evaluation process during the current grant period, which includes
the following: appointed additional External Advisory Board (EAB) members in informatics, COE, education, and
Diversity, Equity, and Inclusion (DEI); completed 85% of prior strategic plan goals, which accelerated several
initiatives in biomarkers, imaging, program grants, and a dramatic increase in philanthropy (2017: $6M; 2021:
$17M); reimagined a bold future via a new strategic plan in partnership with health system leadership; conducted
ad hoc reviews of COE, and emerging cores, validating three new CCSG cores (CRIC, CBC, CAMP); and
facilitated bi-directional community input with a catchment expansion from 36 counties to Wisconsin’s entire 72
counties. Success in an organization provides an opportunity for leveraging achievements and forecasting a new
vision. UWCCC leadership embraced assessments of emerging scientific strengths, surveillance of the oncology
clinical care and research environment, and the eventual application of analysis-driven reorientation. This
occurred through regular and strategic planning meetings of individual focus groups/committees of the cancer
service Line; Executive Leadership Council; Senior Leadership Committee; Directors Committee; Ad Hoc
Advisors; EAB; and annual scientific retreats.
Our strategic planning process reorients UWCCC to leverage strengths and address challenges by expanding
key new Associate Director’s roles in genomics and precision medicine, community engagement, diversity,
equity, and inclusion, and a new senior medical director who will centralize the cancer service line. Dr. Bailey
promoted or externally recruited new Associate Directors in faculty development and education, clinical research,
and informatics. Leadership is accountable for creating an inclusive, respectful, and welcoming environment in
which all members, students, and staff will thrive. All UWCCC leadership roles further the center’s mission by
serving faculty members, employees, trainees, our patients, and our catchment area. Membership has grown
from 198 to 218. Over 11 new initiatives directly address professional growth of trainees and staff. Two new
community advocacy boards provided actionable advice, which led to a dramatic accrual rate increase for
patients with race/ethnicity other than non-Hispanic White patients from 3.4% to 6.3% by 2021. We work
collectively to guide planning and evaluations, create a vision, set goals, assess progress, and set the agenda
for future directions. Leadership determines strategies to leverage the breadth and depth of science on the
University of Wisconsin-Madison campus. Meeting monthly, they identify and foster research capabilities that
will strengthen the UWCCC’s scientific programs and extend cancer focus into new areas.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.